Circadian changes in network excitability and Alzheimer disease pathogenesis

Project Summary
In AD, network hyperexcitability in the form of epileptic activity has a clear diurnal pattern and is more common
at night and during sleep. Our work focuses on the molecular circadian clock as a source of AD-related
hyperexcitability, as it is the mechanism responsible for regulating neurophysiology and excitability in a cell
type-specific manner. The molecular clock regulates excitability through oscillating expression of clock genes
and clock-controlled genes in the neocortex and hippocampus. Inhibitory interneurons, such as parvalbumin
(PV+) interneurons in the hippocampus and cortex, play a critical role in AD-related hyperexcitability, with PV+
cells being the most abundant in the hippocampus and cortex.
Our working model posits that circadian dysfunction in PV+ interneurons contributes to the diurnal prominence
of AD-related hyperexcitability in the inactive/rest phase. The experiments outlined here will test the hypothesis
that AD-related disruption of the cell-autonomous molecular clock in PV+ interneurons disrupt daily changes in
clock-controlled gene expression in a mouse model of AD. In Aim 1 we will measure changes in clock gene
and clock-controlled gene expression in PV+ hippocampal and cortical interneurons. In Aim 2 we will measure
naturalistic behaviors in mouse models of Alzheimer’s using machine learning.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is the most common neurodegenerative disorder and is associated with network hyperexcitability in the brain. In this proposal, we will investigate the role of clock gene and clock-controlled gene expression within Parvalbumin (PV) positive interneurons and describe the differences in behavioral phenotypes of mouse models of AD. Our long-term goal is to establish if regulating PV interneuron excitability may serve as a therapeutic target for this disorder.